Mechanisms controlling early human lung development

Summary
While many of the molecular pathways that govern mouse lung branching have been defined, little is
known about early human lung branching. Our preliminary data show that the molecular and cellular
mechanisms driving branching in the human fetal lung are different from those in mouse. Lung branching
morphogenesis relies on several cellular and molecular events including cell migration, proliferation, proximal-
distal patterning and epithelial-mesenchymal crosstalk. Proximal-distal patterning in the mouse lung is
demarcated by the exclusive expression of Sox2 and Sox9 in the proximal and distal compartments
respectively, and regulated by FGF signaling. Careful analyses of the human lung during the pseudoglandular
stage revealed the presence of a double SOX2+/SOX9+ progenitor cell population in the distal epithelial
buds, that is required for branching. Our preliminary data showed that FGF10 does not induce branching in
the human fetal lung, unlike in mouse lung. In contrast, we showed that FGF18 induces branching in
human lung explants, and a concomitant decrease of FGF18 and smooth muscle cells (SMCs), is
associated with impaired branching. Meanwhile, we observed that SMCs extend to the periphery of the
human developing lung, and seem to arrange prior to the emergence of new epithelial buds. Based on these
observations, we hypothesize that FGF18, but not FGF10, plays an important role in driving human lung
branching through coordinate epithelial/mesenchymal signals leading to SMC differentiation and
migration, that in turn contract to mechanically guide branching morphogenesis in early human lung
development. In the first aim, we will define the role of coordinate epithelial/mesenchymal FGF18
signaling in promoting early human fetal lung development. In this aim we will use complementary gain and
loss of function approaches to A) determine the effect of FGF18 in the branching of human fetal lung
explants, B) define whether FGF18 acts directly on the epithelium to promote branching and maintenance
of SOX2/SOX9 progenitors and C) identify the effect of FGF18 signaling on mesenchymal progenitors and
SMC proliferation, migration and differentiation. In the second aim, we will determine the dynamic and
mechanical functions of SMCs in directing epithelial branching in human fetal lung. In this aim, we will A)
determine in real time how differentiation and dynamic movement of SMCs drive epithelial branching in human
lung explants in vitro, B) determine the effect of SMC contractility on human lung branching, using
inhibitors of F-actin polymerization and myosin activation, and C) determine the epithelial-SMC
interactions required for proper branching of the human lung. Congenital small lung (CSL), also known
as pulmonary hypoplasia, is a common neonatal lung condition affecting approximately that may result from
different insults affecting different developmental mechanisms. Understanding the mechanisms underlying
early human lung development will transform our concepts of human lung development, and thus may allow
for the discovery of possible therapeutic avenues to restore or enhance lung development for neonates with
CSL.

Public health relevance
Project Narrative Congenital small lung (CSL), also known as pulmonary hypoplasia, is a common neonatal lung condition affecting approximately one in 1,000 newborns, resulting in respiratory insufficiency or failure leading to significant morbidity and mortality. Understanding the mechanisms controlling early human lung development and the role of FGF18 signaling and smooth muscle cells in driving airway branching will transform our concepts of human lung development and may allow for the discovery of possible therapeutic avenues to restore or enhance lung development in patients with CSL.